Initiative to Maximize Student Development in Translational Medicine

Initiatives to Maximize Student Development in Translational Medicine (IMSDTM)
Summary Statement
Over the last 20 years many professional organizations have documented that an insufficient number of underrepresented
students are being trained in biomedical sciences, including those trained for research in translational medicine (TM)
despite the significant increase in job opportunities for well-trained TM scientists. Lack of exposure and training
opportunities for historically underrepresented populations (URPs) severely hampers their capacity to fill this national
need. The College of Veterinary Medicine & Biomedical Sciences (CVMBS) at Colorado State University (CSU) proposes to
create a unique training opportunity for URM Pre-doctorates to earn a PhD or DVM/PhD in TM. CVMBS has a strong history
of T32 pre-doctoral training programs as well as T35 summer research experiences for DVM, DVM/MS, and DVM/PhD
students interested in TM, but has seen just a moderate increase in URPs entering graduate programs. We seek to enhance
our efforts in training and recruiting URPs by leveraging pre-existing training programs; as well as develop new pre-
doctorate programs specifically designed to provide URPs with a an inclusive, supportive and comprehensive training
environment for research, communication, and career development in TM. The proposed plan provides comprehensive
and flexible TM training to facilitate basic biomedical and clinical research. To achieve these goals, five objectives are
proposed: (1) Increase the number of PhD students from under-represented backgrounds with interest and aptitude for
TM research to enter a mentored training program. (2) Enhance existing programs by building a flexible and rigorous
research training program for students in basic and clinical research. (3) Encourage, support and enhance TM training and
collaboration through CSU’s new Translational Medicine Institute (4) Facilitate entry into the workforce by providing
training in team research, science communication and professional development experiences. (5) Build social and learning
networks to provide a supportive and inclusive environment, enabling timely completion of the PhD degree. These
frameworks will support our IMSDTM students through individualized counseling, mentoring and advising relationships at
multiple levels. Success will be determined by a comprehensive assessment by the CSU Institute for Research in the Social
Sciences. We will recruit historically underrepresented students to our IMSDTM training program from CSU’s NSF CO-WY
AMP program; Fort Lewis College, a non-Tribal College Native American serving institution; CSU-Pueblo, a Hispanic Serving
Institution with well-established undergraduate training program for Hispanic students; CVMBS undergraduates from
three Departments of Microbiology, Immunology, Pathology, Biomedical Sciences, Environmental Radiological Health
Sciences, and the Cellular & Molecular biology program. This comprehensive training approach will prepare IMSDTM
scholars to successfully complete their PhD degrees and enter careers in the multiple discipline areas found in translational
medicine The IMSDTM cohort will enhance the experience of all our students by increasing diversity of experiences,
thought and perspectives in our graduate programs.

Public health relevance
The Initiative to Maximize Student Development in Translational Medicine (IMSDTM) Training Program will recruit, matriculate and support diverse predoctoral students from underrepresented populations in biomedical research that translates to human clinical applications to address human health and disease globally. Trainees will benefit from the vast expertise of experienced mentors, state-of-the-art facilities, and substantial institutional programmatic resources and extra- mural funding. Together, activities to encourage inclusivity, synergism in training, and unique experiential opportunities will provide diverse cohorts of predoctoral trainees with the necessary skills to confront threats to human health as they embark upon academic or non-academic research careers in translational medicine research.